Cancer research education program (C-REP)

PROJECT SUMMARY: TRAINING AND EDUCATION PROGRAM
While minority faculty in the clinical and translational sector may provide an innovative perspective from
which we identify problems disproportionately plaguing populations of color, they often lack the research
capacity needed to both rigorously evaluate the causal predictors of these problems and identify mechanistic
modes of intervention for the elimination of health disparities. Moreover, minority investigators encounter major
barriers to successful competition for federal research funding, which include but are not limited to: inadequate
research training, a lack of opportunities for professional development, insufficient mentorship, and inadequate
support for research focused on minority populations (Shavers, 2005).
Thus, in response to PAR-18-911, our goal is to partner with Hampton University (HU) faculty in order
to provide hybrid training and education to increase HU research capacity in the area of cancer genomics and
health disparities, while also providing a rigorous curriculum in introductory and advanced biostatistics and
data science, clinical genome science, epidemiology, community-engaged research, health disparities
research, and clinical research methods. The curriculum will be administered through online asynchronous and
synchronous lectures coupled with intensive on-site training sessions in Years 2 through 4 of the proposed
four-year partnership. Our objectives are to: 1) successfully implement the online cancer genomics research
training and education program; 2) design and successfully implement the on-site research training education
program; and 3) conduct a rigorous evaluation of the impact of the proposed training and education program
on building research capacity and increasing research engagement and productivity. Additionally, HU will be
providing extensive insight and guidance to help foster a culture of inclusion, diversity, and equity among
members of the ISMMS research workforce through a series of in-person and virtual lectures.
In summary, we are confident that our proposed, comprehensive, online and on-site training and
education program will increase the competitive success of federal grant submissions by HU faculty for cancer
health disparities genomics research projects, while also providing them with an optimal skill-set that they can
disseminate to the larger HU community of faculty and students.

Public health relevance
Project Narrative: TRAINING AND EDUCATION PROGRAM Diverse investigators play an integral role in identifying novel research questions, perspectives, and solutions to complex biomedical challenges. Yet, diversifying the biomedical research workforce remains a major challenge in the US, despite the fact that underrepresented minorities make up the most rapidly growing segment of the US population. Thus, in a unique partnership between the Icahn School of Medicine at Mount Sinai and Hampton University, we propose to provide hybrid training and education to increase the research capacity, engagement, and success of the HU scientific workforce, with particular emphasis on genetics and genomics and cancer disparities research.